Advancing Endovascular PAD Treatment: Overcoming Critical Knowledge Gaps with MRI-histology

ABSTRACT
Peripheral artery disease (PAD) causes severe morbidity as plaques obstruct blood flow, preventing adequate
perfusion to limbs, which may result in amputation or death. There are one million interventions to treat PAD per
year, emphasizing the high prevalence of this disease. The preferred treatment is percutaneous vascular
interventions (PVI), where vessel plaque is penetrated and threaded (crossed) by a guidewire, followed by a
balloon over the wire and/or other adjunctive devices to open the blood vessel. Unfortunately, PVI fails
immediately for 20% of patients because the plaque proves impenetrable -- meaning patients are put at risk for
no health benefit. Furthermore, after ballooning open there is damage to the vessel wall and vessels block again
within a year for 70% of patients with below-the-knee plaques. These failures then require additional invasive
interventions. The difficulties with PVI are frustrating for the clinicians performing the surgery and needlessly
risky for our patients. There is a fundamental gap in knowledge in how to select patients that benefit from PVI
and how different preparation devices alter vessel wall injury. We propose a two-pronged approach: 1) improve
patient selection for PVI using a novel MRI-histology based anatomic scoring system that identifies patients with
impenetrable plaques; and 2) improve device selection by identifying devices that reduce vessel wall injury during
PVI using histopathologic analysis after PVI in a cadaveric model. Our preliminary data show that our in vivo
MRI-histology method can visualize hard plaque components (both calcium and dense collagen) to decipher
individual patients' plaque morphology and determine which plaques are penetrable. Furthermore, our cadaveric
model indicates differences in vessel wall injury following different preparation devices using detailed ex vivo
plaque analysis post-intervention. Our Specific Aims are:
1. Establish a novel MRI-histology anatomic scoring system that predicts PVI immediate technical failure to
improve patient selection for PVI. We will image patients prior to their PVI with our clinical MRI-histology protocol
to prospectively score individual patients’ plaques to predict successful guidewire crossing.
2. Describe the benefits of using orbital atherectomy before balloon angioplasty versus using balloon angioplasty
alone for various plaque types in arteries below the knee. We will randomize amputated legs from PAD patients
with calcified below-the-knee arteries to undergo plain balloon angioplasty versus atherectomy preparation
device prior to angioplasty. Pre-procedure 3T MRI-histology, intravascular ultrasound, and ex vivo plaque
analysis with histology, will determine vessel wall injury between intervention groups.
We will establish a patient selection process for PVI and define vessel wall response with ballooning only versus
vessel preparation with atherectomy through histologic analysis of cadaveric lesions. Our study will empower
clinical decision-making toward the safest, most effective strategies to ultimately save patient limbs and lives.

Public health relevance
NARRATIVE The current approach for peripheral artery disease (PAD) management is to reopen arteries with a “one size fits all” intervention that does not consider the composition of the plaque, which contributes to the high failure rate of the intervention. To solve this problem, we propose a two-pronged approach to improving PAD management utilizing a novel MRI-histology protocol on below-the knee arteries: 1) creating an MRI-based plaque scoring system that predicts intervention success in vivo and 2) using detailed plaque analysis of vessels ex vivo to assess the degree of vessel wall injury resulting from orbital atherectomy in various plaque types and evaluate its potential in reducing dissections in concentric calcium plaques. This will empower clinicians with objective, rational, and personalized approaches that decrease immediate failures and optimize device choice for PAD interventions.